New Mexico Department of Agriculture Maintenance of the Animal Feed Regulatory Program Standards

PROJECT ABSTRACT
The maintenance of the Animal Feed Regulatory Program Standards (AFRPS) will be carried out
by the New Mexico Department of Agriculture (NMDA), Feed, Seed and Fertilizer (FSF)
Section utilizing the resources and processes established during the implementation process. The
FSF section will continue to use iPassport for controlling all AFRPS documents and materials,
manage the frequency of document reviews and to assign reviews as needed. The FSF section
will continue to use USAPlants to maintain data for feed, seed and fertilizer regarding
registration information, tonnage, regulatory compliance, inspections, samples, complaints and
enforcement actions. FSF staff will participate and be fully transparent in audits and discussions
with the FDA to identify shortcomings and pitfalls encountered in order to either modify the
standards or assist the FDA in improving cooperation and regulatory activities with NM as well
as other state programs. It is anticipated that this project will further develop beneficial
partnerships, an adequate availability of technical expertise, well versed personnel providing
regulatory oversight and compliance assistance, and a federal state relationship ultimately
resulting in a successful nationally integrated feed safety system.

Public health relevance
PROJECT NARRATIVE The Animal Feed Regulatory Program Standards (AFRPS) establishes a uniform foundation for the regulation of animal feed that establishes the safety and integrity of the U.S. animal feed supply and ensures a uniform and consistent approach to feed regulation among states. While many states may not have sufficient resources on their own, participation in and funding provided by this grant opportunity provides the resources to implement and maintain a viable, aligned feed regulatory program contributing to a nationally integrated feed safety system.